Randomized Trial of Specialty Palliative Care Integrated with Critical Care for Clinically Ill Older Adults at High Risk of Death or Severe Disability - Supplement

ABSTRACT
The National Academy of Medicine has identified improving clinicians’ serious illness
communication skills (SICS) as a priority area to improve patient and family outcomes near the end
of life. SICS are particularly important for hospitalized patients with moderate-to-severe Alzheimer’s
disease or related dementias (ADRD) because: 1) patients’ preferences vary substantially regarding
goals of care in this context; and 2) hospitalization often signals a worsening health trajectory with
cascading readmissions and functional decline, and therefore presents an opportunity to engage in
robust goals of care conversations. However, a critical barrier to achieving widespread
improvements in this aspect of care for hospitalized ADRD patients is the absence of a scalable,
empirically-validated way to help clinicians acquire the complex communication skills needed to
engage patients and families in goals of care discussions in the hospital setting.
The parent R01 on which this supplement builds is an RCT among critically ill older patients
assessing the efficacy of an intervention involving goals-of-care conversations delivered by palliative
care (PC) specialists to improve patient and family caregiver outcomes. The broad focus of both the
parent R01 and this ADRD supplement is on caregiver support and patient-centered care through
enhanced clinician-patient-caregiver communication. In light of the workforce shortages for PC
specialists, improving the skills of non-PC specialists, which is the goal of the supplement proposal,
is a critical strategy to increase care quality for hospitalized ADRD patients.
Our goal is to create and disseminate a technology-enhanced intervention that is both
scalable and empirically-validated to help hospital-based physicians and advanced practice
providers (APPs) acquire the skills needed to effectively conduct goals-of-care conversations for
hospitalized patients with ADRD and their families. Therefore, in Aim 1, we will use a nominal group
process to engage a diverse stakeholder panel in the construction of the technology-enhanced SICS
intervention for clinicians treating patients with ADRD. In Aim 2, we will conduct a single-arm pilot
trial to evaluate the feasibility, acceptability, and efficacy (i.e., skills acquisition) of the SICS
intervention.
The proposed work will have high impact because it will yield the preliminary data needed
for a successful R01 application to conduct an RCT to determine the impact of the scalable SICS
intervention on the outcomes of hospitalized patients with ADRD and their caregivers. The project is
innovative because it seeks to develop the first empirically-validated SICS intervention for clinicians
of patients with ADRD that leverages technology to achieve high scalability. The work is feasible in
our hands because we are a team of established investigators with a strong commitment to
improving patient and caregiver outcomes in ADRD.

Public health relevance
PROJECT NARRATIVE It is a national priority to develop training programs to help clinicians acquire communication skills needed for effective goals-of-care discussions with patients with moderate-severe Alzheimer’s disease or related dementias (ADRD) who develop acute illness requiring hospital admission. In this administrative supplement, we will engage a diverse group of stakeholders and use evidence-based methods to develop a scalable, technology-enhanced training program for hospital-based clinicians who treat patients with ADRD who are hospitalized with acute illness. Then we will conduct a pilot trial of the scalable program to assess its usability, acceptability, feasibility, and efficacy.